Facilitating and Supporting Industry Engagement

Project Summary
The Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's
Disease (MassAITC) is a multidisciplinary Center spanning five sites – the University of
Massachusetts Amherst, Brigham and Women’s Hospital, Massachusetts General Hospital,
Brandeis University and Northeastern University – that aims to foster interdisciplinary research
on the development, validation and translation of emerging AI- enhanced technologies to
enhance connections between older adults, caregivers, and clinicians in order to more
effectively support healthy aging as well as the care of patients with AD/ADRD at home. This
supplement aims to enhance our ability to interface with industry partners to facilitate
industry-academic partnerships, assist with development or refinement of research proposals,
provide technical guidance, assist with study designs, IRB applications and reliance agreements,
provide fiscal oversight, and provide guidance on ML-ready dataset curation, and pilot project
deliverables.

Public health relevance
Project Narrative The Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MassAITC) seeks to develop and validate health monitoring devices and artificial intelligence technologies to support healthy aging and Alzheimer's Disease care. The MassAITC will play an integral role in supporting research projects across industry and academia aimed at developing new and innovative AI-enhanced technologies to address these needs.